Succinate signaling in periodontitis induced neuroinflammation and dementia

Alzheimer’s disease (AD) is a degenerative brain disorder leading to dementia. Periodontitis, a chronic,
inflammatory disease, induces systemic inflammation and neuroinflammation. Studies indicate that
patients with periodontitis may be at higher risk of developing AD. Our preliminary data have shown
that succinate, a tricarboxylic acid cycle intermediate, significantly increased in the cerebrospinal fluid
(CSF) from mice with periodontitis. Succinate can act as a signaling ligand extracellularly through
succinate receptor (SUCNR1). We showed that microglial cells express SUCNR1. Interestingly,
knockout (KO) of SUCNR1 significantly reduced the increases of IL1β and microglial activation induced
by periodontitis in mice. The IL1β expression stimulated by administration of succinate or a key
periodontal pathogen Fusobacteria nucleatum (Fn) lysate was significantly reduced in the primary
microglial cells derived from KO mice. We further demonstrated that succinate can stimulated the growth
and virulent gene expression of Fn and altered the oral microbiome in mice. In response to Funding
Opportunity Announcement “Research on Current Topics in Alzheimer's Disease and Its Related
Dementias” (PAR-22-093), we postulate that succinate elevation in periodontitis induces
neurodegeneration directly via SUCNR1 activation in microglial cells, and indirectly via
systemic inflammation and dysbiosis. In Aim 1 we will reveal how SUCNR1 activation in microglia
modulates neuroinflammation in vitro and in vivo. Microglia are crucial for the homeostasis within the
brain and our preliminary data showed that the stimulation of the nuclear factor-κB (NF-κB) pathway
and IL-1β expression by succinate in microglia is SUCNR1-dependent. We will study the mechanism of
microglial succinate/SUCNR1 signaling on neuroinflammation in primary microglia, littermate control
(Ctrl) and microglial-specific SUCNR1 deficient (mKO) mice. In aim 2 we will assess the impact of
targeting SUCNR1 on cognition impairment with chronic periodontitis. We will target SUCNR1 using
mKO mice in Exp. 1 in which 20-month-old, both genders of littermate ctrl and mKO mice will be
assigned randomly to have sham or chronic periodontitis for 4 months before cognition tests and
sample collections. In Exp. 2 we will employ 5xFAD mice with periodontitis to determine if blocking
SUCNR1 by an antagonist will alleviate periodontal bone loss, neuroinflammation and recognition
deficits. The SUCNR1 antagonist treated mice and their age and gender-matched, sham/veh treated
WT, and 5xFAD mice will be assessed longitudinally at 4-, 7-, and 12-month-old for neuroinflammation
and cognition impairment. The proposed research will discover a novel mechanism of succinate
signaling in periodontitis and AD nexus and provide a new therapeutic target for AD.

Public health relevance
Project Narrative Periodontitis is chronic gum inflammation leading to systemic inflammation and neuroinflammation and may subsequently promote the pathogenesis of Alzheimer’s disease. The proposed study will identify a novel mechanism by which periodontitis increases succinate in cerebrospinal fluid and activates succinate receptor in microglia to induce neuroinflammation and neurodegeneration. The study will provide a potential therapeutic strategy by targeting succinate receptor.